NCI SUPPORT FOR THE EXISTING AUTOMATED SELF-ADMINISTERED 24-HOUR DIETARY ASSESSMENT SYSTEM

THE CONTRACTOR SHALL PROVIDE SERVICES TO SUPPORT, UPDATE, MAINTAIN, FURTHER DEVELOP AND REFINE THE EXISTING AUTOMATED SELF-ADMINISTERED 24-HOUR DIETARY ASSESSMENT SYSTEM